Trans-Omics for Precision Medicine (TOPMed) Artificial Intelligence Coordinating Center (AI-CC)

ABSTRACT
Please see the Volume 1. Technical Proposal.

1. Background and Purpose
The Women’s Health Research Initiative (WHRI) recognizes that women have historically been
underrepresented in biomedical research, and as a result, there is a lack of understanding of sex
and gender-related differences in risk factors and health outcomes. The Initiative rightly
emphasizes a need for the application of novel analytical approaches to rich datasets to elucidate
these differences, improve our understanding of Women’s Health issues, and inform more effective
medical interventions.
Initiated in 2014, the Trans-Omics for Precision Medicine (TOPMed) Program is part of the
National Heart, Lung, and Blood Institute’s (NHLBI’s) broader precision medicine initiative which
aims to improve the prevention and treatment of heart, lung, blood, and sleep (HLBS) disorders
through tailored and individualized disease treatments. The TOPMed program generates whole
genome sequencing (WGS) and other –omics data and integrates them with molecular, behavioral,
imaging, environmental, and clinical data to better understand the biological processes that
underlie HLBS disorders. Petabytes of –omics, phenotypic and environmental exposure data
generated by TOPMed from approximately 200,000 research subjects across 90+ studies are fed
into NHLBI’s BioData Catalyst (BDC) ecosystem and the Database for Genotypes and Phenotypes
(dbGaP) for use by scientific investigators.
Data collected as part of the TOPMed Program have significant potential to improve women’s
health outcomes, however, due to the complexity and multi-factorial nature of the data, novel
methods are needed to discover and measure –omics-level sex differences. Recent advances in
Artificial Intelligence (AI) and Machine Learning (ML) methods have shown significant promise to
uncover previously unknown statistical associations across a range of therapeutic areas,
particularly when combining different types of data, such as whole genome sequences, clinical
measures, and medical imaging. By bringing together TOPMed data, experienced AI and ML
researchers, and subject matter experts in Women’s Health, with the analytical infrastructure
provided by the BDC, we will be able to address the long-standing sex-related disparities in
biomedical research.
The NHLBI is establishing the Artificial Intelligence –
Coordinating Center (AI-CC) to serve as a central hub for
coordinating research projects and bringing together AI
and scientific experts to collaborate on innovative
approaches to analyze and interpret TOPMed data.
Additionally, the AI-CC may support other areas of
NHLBI’s research interest such as the use of AI on
imaging and –omics data in the areas of radiomics and
radiogenomics to advance the understanding of chronic
lung disease, especially idiopathic pulmonary fibrosis.
Westat is well-positioned to implement and operate the
AI-CC due to the significant efficiencies that will be
gained from our role as the TOPMed Administrative
Coordinating Center (ACC). Our experience and
capabilities include: (1) a strong team of staff that
routinely collaborates with NHLBI, TOPMed investigators, and the BDC team; (2) established and
effective processes, procedures, and systems that can easily and quickly be adapted and applied to
the AI-CC; (3) familiarity with TOPMed data and associated analyses; (4) substantial experience
and established processes for managing sub-Other Transaction Authority (OTA) awards; and
(5) experience in AI and ML methods. Where feasible, to maximize synergy and to gain most
efficiencies, we have selected the staff that currently support TOPMed, augmented with other
relevant experts. Our approach will not only leverage the efficiencies afforded by the TOPMed
program, but also provide an efficient and scalable mechanism to support additional research
areas, beginning with a focus on lung disease.